Development of a Novel Biosensor to Accelerate Investigations of the Gut Microbiome

The human gut microbiome is a promising avenue of precision medicine that has been linked
to immunology, metabolism, neurodegenerative disease, cancer, and infectious disease.
However, clinical translation of these findings has been limited. A key barrier to translation is
that existing data generation tools cannot support the creation of the large, time-longitudinal
datasets needed for effective discovery & reproduction of clinically actionable microbiome
biomarkers. Without strong data, investigators today have reduced ability to advance the
microbiome's precision medicine potential.
BiomeSense is developing the first dedicated tools for large-scale, standardized, and low-cost
microbiome data generation to eliminate the barriers to large, longitudinal microbiome
datasets. These consist of the GutLab, a novel hardware technology for continuous,
standardized data generation; and MetaBiome, a novel bioinformatics software platform to
standardize and streamline metanalyses. At the time of the grant period, GutLab prototypes
will have undergone laboratory validation and preliminary at-home testing. In this Phase II
project, BiomeSense will validate the real-world functionality of the GutLab prototypes in a
large observational study. User-testing of GutLab prototypes in the home environment will
allow for technical stress-testing and user feedback, while data generated by these tests can
be fed into MetaBiome for improved algorithm development and validation. This approach will
simultaneously benefit hardware and software development pathways. Aim 1 describes the
execution of the observational GutLab study, while Aim 2 describes the use of this
dataset to develop a novel analytical component for Metabiome to forecast microbial
communities.
At the end of Aim 1, BiomeSense will have created one of the highest-quality, largest, and
densest metagenomic datasets in existence. The data from this study will be available through
BiomeSense's reference cohort database for use in future metanalyses, and for the continued
development of proprietary analytical techniques. In the long term, the forecasting models
generated in Aim 2 can be applied in the clinic to monitor disease progression or detect
anomalies and critical transition points days or even weeks before the events occur. In the
short term, this project will support the field-wide adoption of BiomeSense's technology, which
will routinely enable the discovery of microbiome-based biomarkers and translation into
consumer facing diagnostics & therapeutics.

Public health relevance
Despite the human gut microbiome's potential to improve disease identification and progression, therapeutic response, public health, and more, microbiome-based precision medicine is rarely applied in clinical practice due in part to a field-wide struggle to discover and reproduce clinically actionable biomarkers. BiomeSense is developing the first dedicated tools for large-scale, standardized, and low-cost microbiome data generation and analytics to eliminate the barriers to large, longitudinal microbiome datasets. At the end of this project, BiomeSense will have validated performance of a novel microbiome data generation technology, developed a microbial forecasting algorithm that can be applied to biomarker discovery and other clinical applications, and created a large, densely sampled metagenomic dataset to power future development.